Clarifying engineered bioabsorbable metals tissue-biomaterial interface and regeneration

The long-term goal of research in my laboratory is to develop a technical design framework that can be used as
a platform to engineer precision bioabsorbable metal materials capable of instructing the wound healing / tissue
regeneration response – a pathway that all implantable biomaterials evoke. Bioabsorbable metals are attractive
biomaterials to create fully regenerative medical implants for a variety of clinical applications. While the
biocorrosion mechanism of bioabsorbable metals has been described extensively in vitro, it remains ambiguous,
and unpredictable in vivo. We hypothesize this is due to the complex temporal interactions from wound healing
and inflammation. Research from my lab has demonstrated how bioabsorbable metal materials interact with
reactive oxygen and reactive nitrogen species (ROS-RNS) produced from lipopolysaccharide stimulated
macrophages, independent of physiological antioxidant mechanisms. Importantly, this has been correlated with
changes in the materials bioabsorption rate, detailing an intimate feedback loop between bioabsorbable material
biocorrosion and inflammatory ROS-RNS generation. We have also shown that small changes in bioabsorbable
metals yield dramatic differences in inflammation / wound healing. In this MIRA, my lab will determine the
mechanisms of in vivo biocorrosion and uncover the most dominating biomaterial factors which govern the
overall tissue-material response. Our goal is to address this gap in knowledge by elucidating the complex
material - inflammation driven ROS/RNS axis, unique to bioabsorbable metal implants due to their redox active
biocorrosion process. We will accomplish this by having three primary focus areas. In focus area 1, we will study
how bioabsorbable metal material characteristics affect the progression of inflammation and wound healing in a
generalized subcutaneous implant model. We will employ serial bioluminescent imaging with commercially
available bioluminescent reporter mice and injectable ROS/RNS sensitive probes to quantitatively measure
inflammation progression vs. material characteristics. In our second focus area, we will determine the
inflammation driven corrosion mechanism of bioabsorbable metals by using well established in vivo cell depletion
models towards macrophages and neutrophils (key cellular modulators of tissue regeneration) at different
healing phases. This will provide valuable insight into the biocorrosion sensitivity of bioabsorbable metals to
inflammation. In the third focus area, we will use semi-quantitative elemental imaging at the interface of implanted
biomaterials to describe how implant derived metals are accumulating. Our previous work using elemental
imaging of implants has found that macrophages situated at the interface directly interact with implant derived
metal containing biocorrosion products. Two major outcomes from this work will be a 1) a precise description of
the inflammation driven corrosion mechanism of bioabsorbable metals and 2) technical design framework, that
can be used to engineer bioabsorbable materials. My expertise in biomedical engineering, material science, and
cellular/organ physiology positions me to execute this research program.

Public health relevance
Narrative Bioabsorbable metals are attractive biomaterials which can be used to create fully regenerative medical implants for a variety of clinical applications. While the biocorrosion mechanism of bioabsorbable metals has been described in the laboratory, it remains ambiguous and unpredictable in real practice largely due to the complexities of the host biological response towards them and the materials’ intrinsic bioactive nature. By investigating the bioabsorbable metal-tissue interface, our lab will ultimately develop a technical design framework that can be used to engineer precision bioabsorbable metal materials, capable of optimizing the natural inflammatory/wound healing response.